Randomized Trial of Stepped Care for Suicide Prevention in Teens and Young Adults

Parent Award Abstract
We propose a rigorous randomized trial to evaluate an innovative stepped care for suicide prevention
intervention for adolescents and young adults, compared to a zero suicide (ZS) program initiated by a health
system. An effective ZS strategy for this age group is critically needed because this is a developmental period
when: 1) suicide is the second leading cause of death, accounting for more deaths than any medical illness; 2)
suicidal tendencies and behaviors often first occur in this age span; 3) rates of suicide and suicide attempts
(SAs) increase dramatically; and 4) effective intervention can reduce risk, suffering, and costs over lifetimes.
The project combines a partnership with a health system that has strong infrastructure and commitment
to quality improvement for ZS with a research team that has successfully implemented collaborative stepped
care interventions in health systems and has expertise in clinical, health services, economics, and policy
research and dissemination. We will identify and enroll 300 youths ages 12-24 with elevated suicide and SA
risk. Eligible youths will be randomized to: 1) zero suicide best practices, which emphasizes health system
quality improvement using the ZS toolkit (ZSBP, www.sprc.org); or 2) ZSBP+ stepped care for suicide
prevention. Prior research demonstrates the value of similar interventions for improving patient outcomes,
rates of care, and continuity of care- a critical issue for ZS efforts, as many youths discontinue care prematurely
despite continuing risk. The ZSBP+ approach uses: 1) risk assessments to triage youths to appropriate care
levels; 2) Care Managers to deliver CBT and DBT skills training and support primary care clinicians with
patient evaluation and treatment; 3) internet eCBT and therapeutic DBT skills video plus access to coaching
support (24/7) for lower risk youths, with stepped up in-person group and/or individual treatment added for
higher risk youths; and 4) regular monitoring of patient outcomes, with real-time feedback to clinicians to
facilitate decision-making and use of the stepped care algorithms. The intervention period is 12 months: 6
months of acute treatment; and 6 months of continuation treatment. Outcomes are assessed at baseline and at
3, 6 and 12-month follow-ups. We hypothesize that, compared to youths in ZSBP, youths randomized to
ZSBP+ will have significantly lower rates of fatal and nonfatal SAs over time (primary outcome) and will show
improvements on secondary outcomes (suicide events over time, self-harm episodes, depressive symptoms).
We will also conduct cost effectiveness analyses. Results will provide critical information for health systems
and science regarding the potential to achieve ZS goals by integrating state of the art science with practice
quality improvement. ZSBP+ stepped care for suicide prevention has potential for broader sustained adoption
within the health system and national dissemination, enhancing our capacity to meet the ZS challenge.

Public health relevance
Study Name: Randomized Trial of Stepped Care for Suicide Prevention in Teens and Young Adults Project Narrative: Suicide accounts for more deaths in teens and young adults than any medical illness. This study tests an innovative stepped care approach for integrating evidence-based suicide prevention for teens and young adults within primary care and emergency services. This approach has potential for saving lives and suffering.